The Role of RERE and SPEN in the development of 1p36 Deletion-Related Congenital Heart Defects

ABSTRACT
Congenital heart defects (CHDs) are seen in ~70% of individuals with 1p36 deletion syndrome and are a
major cause of morbidity and mortality. RERE and SPEN are nuclear receptor coregulator encoding genes
located in CHD critical regions on chromosome 1p36. We have shown that their haploinsufficiencies contribute
to the development of 1p36-related CHD and individually cause syndromic forms of CHD with ventricular septal
defects (VSDs) being particularly common. In this application, we will elucidate the morphogenetic and
molecular mechanisms by which RERE and SPEN function during cardiac development.
Using our unique mouse resources, we have shown that systemic or endocardial-specific RERE deficiency
causes endocardial cushion hypoplasia and VSDs by decreasing levels of endothelial-to-mesenchymal
transition (EndMT) and mesenchymal cell proliferation in the atrioventricular (AV) canal. Our published and
preliminary data suggest that RERE functions in the AV canal by positively regulating the expression of Spen,
Gata4, Bmp6, and Bmp7, all of which have been implicated in the development of VSDs. Similarly, we have
shown that systemic or endocardial-specific SPEN deficiency causes endocardial cushion hypoplasia and
VSDs, and that Rere and Spen interact genetically in VSD formation. These results lead us to hypothesize that
SPEN deficiency triggers morphogenetic changes in the developing AV canal that are similar to those caused
by RERE deficiency. Since SPEN and RERE encode nuclear receptor coregulators and interact with similar
proteins including RARα and HDAC1, we also hypothesize that they function within the same pathway to
regulate Gata4, Bmp6, and Bmp7 transcription in the developing AV canal. To test these hypotheses, we
propose two Specific Aims.
In Specific Aim #1, we will determine the morphogenic mechanisms by which SPEN deficiency
causes VSDs using AV canal explant and immunohistochemical studies. Specifically, we will determine if
SPEN deficiency leads to decreased levels of EndMT and mesenchymal cell proliferation, and if it also triggers
increased levels of mesenchymal cell death not seen in RERE deficient embryos. In Specific Aim #2, we will
determine the molecular mechanisms by which SPEN deficiency causes VSDs and how RERE and
SPEN interact using a variety of molecular techniques. Specifically, we will determine if SPEN functions
similarly to RERE in regulating the expression of Gata4, Bmp6, and Bmp7, if RERE can activate the SPEN
promoter, and if RERE and SPEN interact in a complex to drive the transcription of their target genes.
The knowledge gained from these experiments will serve as a foundation from which therapeutic and
preventative interventions can be developed, not only for individuals with 1p36 deletions or pathogenic variants
in RERE and SPEN, but also for a much larger group of individuals at risk for VSDs. The innovative mouse
models used in this proposal will provide a platform on which these interventions can be tested.

Public health relevance
Project Narrative Genes on chromosome 1p36, including RERE and SPEN, are deleted or altered in some people who are born with heart defects. In these studies, we will use mouse models to learn how altering RERE and SPEN leads to abnormal heart development. These studies will help us provide better medical care to individuals with heart defects and may ultimately lead to the development of new ways of preventing or treating these defects.